Methodologies Toward the Enantioselective Vicinal Stereocenter Generation and Applications to Complex Molecule Synthesis

Project Summary/Abstract The lactone heterocycle is a privileged motif that appears in molecules of biological and materials importance. As a prevalent heterocyclic scaffold in chemical therapeutics, the lactone motif is featured in a number of drugs such as Irinotecan and Simvastatin. Moreover, lactones are a versatile building block in a plethora of different applications, such as in the preparation of aliphatic polyesters used as biodegradable devices in surgery and plastics. Due to their prevalence in therapies and biology, novel and innovative methodologies to access lactones in an enantioselective fashion remains highly sought after. As the construction of vicinal stereocenters, particularly all-carbon quaternary centers, is an ongoing challenge in synthetic chemistry, the disclosure of a method for the synthesis of enantiomerically enriched lactone scaffolds containing vicinal stereocenters is highly desirable. Modern methods to prepare this structural unit often require the use of a strong base, limiting applicability and functional group tolerance. The proposed research aims to develop the first asymmetric sequential visible-light photoactivation and Pd-catalyzed cycloaddition reaction capable of accessing enantiomerically enriched lactones scaffolds that possess vicinal stereocenters. If successful in developing the proposed transformation, a concise enantioselective synthesis of mehirugin C, a complex guaianolide, will be pursued to both assess the utility of the method as well as provide rapid access to a compound with interesting therapeutic indications.

Public health relevance
Project Narrative The asymmetric construction of vicinal stereocenters, in particular all-carbon quaternary stereocenters, is an important challenge in organic chemistry. Due to the prevalence of vicinal stereocenters in numerous biologically active molecules and natural products, the need to develop concise and powerful methods to access these motifs is of upmost importance. In order to address this need, the aim of the proposed research is to develop a vicinal stereocenter synthesis of lactones asymmetrically utilizing a sequential visible-light photoactivation and Pd-catalzyed asymmetric allylic alkylation using readily available vinyl carbonate derivatives and α-diazaoketones.